The Ohio State University as a Lead Academic Organization (LAO) for the Experimental Therapeutics Clinical Trials Network

PROJECT SUMMARY The LAO OH-007 UM1 research group consists of an experienced and innovative multi-disciplinary team of basic scientists and clinical investigators dedicated to finding effective new therapies for patients with cancer utilizing the resources available through CTEP NCI. The Ohio State University Comprehensive Cancer Center (OSUCCC) is a comprehensive biomedical research campus with strong collaborations between experienced investigators from multiple oncologic disciplines and a vibrant pattern of discovery in the basic sciences. The present consortium includes OSUCCC in collaboration with the University of Kentucky Markey Cancer Center (MCC) and the University of Utah Huntsman Cancer Institute (HCI) with whom they have had strong relationships in the past, and the University of North Carolina Lineberger Comprehensive Cancer Center (UNC LCCC) who joined LAO OH-007 one year ago. This application is being submitted to request additional funds for UNC, an Affiliated Organization to OSU, an ETCTN UM1 Lead Academic Organization. The funds will allow UNC to continue to participate in the ETCTN including leadership of two ETCTN studies led by Drs. Claire Dees and Joshua Zeidner (described in more detail below), continued accrual to ETCTN studies and participating in other activities including LOI submission and PTMA applications. The present proposal contains a request for funds to support the efforts of two research coordinators and two investigators. Going forward, there will be a continued concerted effort to incorporate the UNC LCCC group into the daily workings of its new home LAO so that study accrual and scientific discovery at this institution can be supported and enhanced. This consortium is committed to accruing a minimum of 100 patients per year to ETCTN studies and it is foreseen that the addition of the UNC LCC phase I group will contribute to this goal in a significant manner.

Public health relevance
PROJECT NARRATIVE The Early Therapeutics Clinical Trials Network (ETCTN) at The Ohio State University (OSU) will identify new agents with promising laboratory studies and develop them into new drugs for the treatment of patients with advanced cancer who have exhausted their treatment options. Physicians, nurses and research coordinators will carefully monitor patients receiving these drugs to make sure that they are safe. Patients will also undergo sampling of their blood and have their tumors biopsied. These tissues will be analyzed by modern methods to determine the levels of the new drug in the bloodstream and test whether they are having the predicted effect on the cancer cells. The aim of the clinical study may be to simply determine if the drug can be given safely (phase I) and in other instances the goal of the study will be to see whether the new drug or drug combination can shrink the tumor and enable the patient to live longer. The consortium will consist of OSU, the University of Kentucky, University of North Carolina and the University of Utah in order to bring the evaluation of novel agents to four states with a high burden of cancer.